Alzheimer Biomarker Consortium - Down Syndrome (ABC-DS)

Overall Abstract
Alzheimer disease (AD) is the most common cause of dementia in the general population and the numbers of
people living with the disease are rising exponentially. A similar event is occurring in the community of people
with Down syndrome (DS) due, in part, to genetic risk (trisomy 21 and lifelong overexpression of APP) leading
to overproduction of Aβ, combined with longer lifespans. The study of DS affords an opportunity to understand
the timing and sequence of pathological changes associated with AD. An overarching theme of the Alzheimer’s
Biomarkers Consortium – Down Syndrome (ABC-DS) is to characterize AD in DS, an issue of major and growing
significance. Data generated from ABC-DS are necessary to determine if the AD pathological cascade is the
same between DS and late onset AD (LOAD) or whether the pathogenic staging has distinct features. Parallels
between the two highlights the importance of research with people with DS for advancing our overall
understanding of AD, which in turn can form the basis for clinical trials. To that end, ABC-DS assembles an
exceptional and highly collaborative research team that will follow a cohort of people with DS to test hypotheses
related to 1) how AD in DS may parallel sporadic AD within an amyloid, tau, neurodegeneration AT(N) framework
and to identify modifiers of risk of conversion/progression (Project 1); 2) to identify genetic modifiers of the
development of AD in DS (Project 2); and 3) to translate outcomes to a precision medicine framework and
expedite clinical trials (Project 3). We will acquire harmonized clinical and neuropsychological outcomes (Clinical
Core), neuroimaging outcomes (Neuroimaging Core), bio-fluids and genetics measures (Omics Core) and
neuropathology data from autopsy (Neuropathology Core). To rapidly disseminate information to our DS
communities and to engage underrepresented minorities, we have a Core dedicated to outreach, recruitment
and retention (ADDORE Core). Lastly, to build upon nationwide efforts to identify targets for interventions to slow
or prevent AD, our Biostatistics and Data Management Core will make high quality data from all aspects of our
study available to qualified researchers by distributing outcomes through LONI and ATRI. Following the lead of
outstanding established AD networks (ADNI, DIAN), ABC-DS will make a significant contribution to national
efforts to improve the quality of life of our aging population through advancing progress toward effective
prevention and treatment of AD.

Public health relevance
Overall Project Narrative Alzheimer's disease (AD) is a major public health crisis for our aging population. People with Down Syndrome (DS) are at high risk for AD and because of their unique biology and provide an unparalleled opportunity to develop biomarkers of preclinical AD. Reliable biomarkers of preclinical AD will enable new options for intervention and promote health for people with DS and in the general population.